Integrative network modeling of bulk and single-cell sequencing data to characterize multi-scale cell architecture

Abstract
Single cell sequencing technology enabled us to identify the aberrant molecular alterations in diseased cells
presenting altered signaling pathways and emergence of disease-associated cell populations, leading to multi-
scale cell architectures in disease tissue micro-environment. However, drawbacks such as low sequencing
depth per cell, expensive costs and loss of cross-cell signaling information have hindered its broader
applicability to large-scale cohorts. On the contrary, clinically well-defined, multi-modal and high-depth bulk-
based sequencing data are abundantly available in public domain, and can be utilized to assemble robust
molecular models of the genetic diseases, and infer cell population abundances in the samples. Especially,
network biology approaches have been effective for integrating large-scale and diverse biomedical datasets in complex
human diseases, and dissect the disease mechanisms and novel therapeutic strategies. Thus, a systems approach to
synergistically utilize these complementary aspects of bulk and single-cell sequencing data is urgently needed to
construct the robust molecular models of disease mechanisms while addressing the multi-scale nature of cell
architectures in diseased tissues. Firstly, we will systematically investigate multi-scale cell architectures by
developing a novel unsupervised cell clustering approach, single-cell recursive multi-scale clustering via local
embedding (scRECIEM). Within scRECIEM, a novel cell-cell network construction algorithm will be developed
by embedding each cell with its nearest neighboring cells on topological sphere, and yield computation
complexity that linearly scales with the number of cells when parallelized. This will be accompanied by a top-
down divisive clustering approach that adaptively utilizes informative features at each split, which is guided by
network compactness measure, υ(α). These will identify a hierarchy of cell clusters captured at different
resolutions. Secondly, we will develop integrative multi-scale network analysis (iMUSNET) framework to
construct data-driven and mechanistic network models of disease etiology by utilizing the context-matched bulk
samples. Within iMUSNET, the context-matched pairs of bulk and single-cell cohorts will be systematically
collected, and we will construct multi-scale gene interaction networks capturing diverse co-expressed modules
at different resolutions. These gene modules will be tested for enrichments with a compendium of clinico-
genomic gene signatures curated within the bulk cohort. Key driver analysis will systematically look for
potential up-stream regulators of the clinic-genomic signatures by leveraging the network model topology.
Further, we will infer abundances of the context-matched single-cell clusters with high accuracy by utilizing the
scRECITE-inferred cell phylogeny, and these will inform relevant disease associated cell populations in the
bulk cohort. Overall, iMUSNET will generate a number testable hypotheses as potential regulators and
subnetworks underlying the disease of interest.

Public health relevance
Narrative This study aims to develop an integrative modeling framework of complex genetic diseases to utilize high- resolution cell architecture from single-cell sequencing data, in conjunction with large-scale bulk sequencing data. We will systematically identify context-matched pairs of publicly available bulk and single-cell studies, characterize multi-scale cell architectures by a novel unsupervised cell clustering approach, and construct network models integrating across molecular modalities and cellular resolutions. The network models will be validated by genetic or chemical perturbation data in model systems from public databases, and shed lights on underpinning mechanisms and potential therapeutic strategies.